PROMACE-CYTABOM TREATMENT FOR ANGIOCENTRIC IMMUNOPROLIFERATIVE LESIONS

This protocol was designed to improve the prognosis of patients with all grades of angiocentric immunoproliferative lesions. Six patients have been entered on study. All six patients have achieved a complete response and 2 have relapsed. One relapsed patient has since undergone bone marrow transplantation and remains in second CR lasting 1.5+ years. The second relapsed patient is currently undergoing ABMT and is too early to evaluate. No patient has died. More patients and longer follow-up are necessary to draw any conclusions.